Targeting synaptic dysfunction in lissencephaly

ABSTRACT
Malformations of cortical development (MCD) are associated with drug-resistant epilepsy, severe intellectual
disability and other debilitating co-morbidities. The current proposal is focused on lissencephaly, a severe brain
malformation resulting from deletions or mutations in the LIS1 gene. Our work has showed that mice with
germline heterozygous mutations in Lis1 exhibit defective neuronal migration during embryonic development
and a striking enhancement in glutamate neurotransmission associated with Lis1 deficiency and does not
require neuronal disorganization. Building on this work, and our exciting preliminary data suggesting cell
adhesion molecules at the synapse might have therapeutic potential in Lis1 mutant mice, we propose a series
of pre-clinical translational studies to test whether glutamatergic synapses can be targeted as a disease
modifying therapy in lissencephaly. Our approach involves a combination of sophisticated cellular, molecular,
electrophysiological and behavior approaches in Lis1+/- mice and human-derived patient neurons. If successful,
our results will provide important new information about the effects of genetically-based malformations in
driving neurodevelopmental disorder pathologies in vivo and would provide critical proof-of-concept for the
therapeutic potential of modifying synaptic function that could be translated into a new targeted therapy for
Lis1-associated lissencephaly.

Public health relevance
PROJECT NARRATIVE Malformations of cortical development are extremely common, but there are no therapies. The proposed research will test a novel gene therapy approach for treating lissencephaly that targets the underlying synaptic dysfunction associated with the disorder.